DDI &ZIDOVUDINE COMPARISON IN AIDS OR ARC PATIENTS ON LONG TERM ZIDOVUDINE

This study is designed to compare the effect of ddI with that of AZT in treatment of patients with AIDS or ARC who have taken AZT for 12 months or longer.